Theory and Measurement of Cell Population Dynamics with Cell-Cell Interaction (TMCC)

Understanding the complex multicellular organisms has long focused on gene networks (because genes interact)
but of equal importance is the dynamics of cell populations (because cells interact). A tissue is a cell society
comprised of a variety of cell types whose the relative numbers are held at a stable, defined ratio despite the
fact that these cells grow (divide) at distinct rates. How does the tissue ensure stability of cell type identities and
tissue composition yet allows for flexibility, e.g. during regeneration when cell types and their ratios change?
From single-cell resolution analysis we now know that any cell population, even of a single type, is actually a
heterogeneous mix of subpopulations of different (sub)types. Therefore, cell population dynamics is more
complex than originally thought. Traditional models must be revised to integrate all the following properties in
one formalism: 1.Non-genetic heterogeneity, the co-existence of cells in distinct (meta)stable states x_i
(functional states, subtypes) forming subpopulations i of size n_i which collectively define a stable population
state n; 2. State transitions between these subpopulations, i to j, possibly reversible, at rates M_ij; 3. Net growth
rates g_i that differ in these subpopulations, allowing for competition; and 4. Cell-cell interactions via specific
signals (within and between subpopulations) that may affect M_ij or g_i. None of existing theories of the dynamics
of an ensemble of entities, ranging from ecologies to chemical reactions to cell populations, consider all these
elements. Hence, a new theoretical framework, nonlinear population balance analysis which is based on the
broader theory of non-linear stochastic dynamical system is proposed. The scholarly goal of this collaborative
project is to advance THEORY but it involves EXPERIMENTS that use a combination of single-cell (sc) RNASeq
and a newly invented cell-barcode method to overcome the shortcoming of scRNASeq which allows only
destructive snapshot measurements. PART I (THEORY) will first establish a formal framework to describe the
relationship of growth and transition rates under cell-cell interactions and the abundance n_i of subpopulations
to predict existence of (multiple) stable population configurations n (Aim 1). A modeling framework to analyze
the barcode data will be developed (Aim 2). PART II (EXPERIMENT) will measure these quantities with scRNASeq
to determine the transcriptomes that define the cell state xi in 1000s of cells and identify the subpopulations.
This will be combined with a new method of cell-unique, inherited and expressed DNA-barcodes that will permit
the tracking cell lineage dynamics that reveals dynamics about growth and state transition rates (Aim 3). Applying
this analysis to mixed cultures of cancer cells and fibroblasts (with implications for cancer) whose interactions
will be manipulated by neutralizing antibodies (Aim 4), the theory predictions, whose chief novelty is the role of
interactions, will be tested. This project is not ad hoc “mathematical modeling” of a given instance, which is
common in systems biology, but develops a general theory of a class of systems which plays an eminent role
for metazoan biology and in doing so will facilitate future efforts in modelling of a variety of specific instances.

Public health relevance
PROJECT NARRATIVE The tissue of multi-cellular organisms consists of cell populations of a variety of cell types that divide at different rates, can convert into each other and interact with each other, which results in a complex cell population dynamics that determines tissue stability in health and instability in disease. Existing theories of cell populations use the analogy of animals in ecosystems and thus do not consider conversions between species (or cell types) and their interactions together. This project will erect a new theoretical framework and test it using new single- cell molecular profiling of cell populations to better understand and model cell population dynamics.